Understanding the chlamydial developmental cycle at the single cell level

Project Summary/Abstract
The bacteria in the chlamydiales order are obligate intracellular parasites of eukaryotic cells. They are reliant
on a developmental cycle consisting of at least three phenotypically distinct cell forms termed the reticulate
body (RB), the intermediate body (IB) and the elementary body (EB). The EB is infectious but does not
replicate. The RB replicates in the host cell but is non-infectious, while the IB is an intermediate form that
transitions to the EB form. Completion of this developmental cycle is central to chlamydial pathogenesis. Within
this order, the genus Chlamydia contains the causative agents of a number of important pathogens of humans.
C. psittaci causes zoonotic infections resulting in pneumonia, while C. pneumoniae is a human pathogen that
causes respiratory disease and is linked to atherosclerosis. Biovars of C. trachomatis are the causative agents
of trachoma, the leading cause of preventable blindness worldwide, as well as sexually transmitted infections
with the potential to cause pelvic inflammatory disease and infertility. Irrespective of the resulting disease, all
chlamydial species share the same obligate intracellular life cycle and developmental cell forms. The
mechanisms that regulate the development of the distinct cell forms are currently poorly understood. Our
preliminary and published data indicates the cycle should be broken down into four stages; EB germination,
RB amplification/maturation, IB production, and EB formation. Understanding these forms and their
contributions to the developmental cycle and pathogenesis has been obfuscated by the mixed cell environment
of the chlamydial inclusion which occurs as early as after the first few rounds of replication. Therefore, we will
pursue two aims focused on understanding the regulation of gene expression in these populations, and the
impact this regulation has on the infectious cycle. In Aim 1, we will develop a CRISPRi knockdown screen
to assess the role of essential genes on cell type regulation. Cell type function is likely crucial in
establishing the developmental cycle, facilitating amplification and disseminating the infection. Chlamydia has
two typeIII secretion system translocons that are expressed in distinct cell types. The translocon is involved in
interacting with target host cells to secrete effectors across the target cell membranes, thus facilitating
communication between the bacteria and the host cell. In Aim 2, we will investigate the role of cell type
specific expression of the two typeIII secretion system translocons. Completion of these aims will lead to
a more complete understanding of the regulation underlying the developmental cycle, allowing for careful
dissection of the effects of mutations, chemical agents, ectopic expression of regulatory proteins, and
therapeutic treatments on the different aspects of the cycle.

Public health relevance
Project Narrative: Bacteria of the genus Chlamydia cause serious infections including sexually transmitted diseases and the potentially blinding ocular infection, trachoma. All Chlamydiae depend on the transition between an infectious Elementary Body (EB) form and a replicative Reticulate Body (RB) form to cause disease. This project aims to describe the molecular details that regulate cell type differentiation using novel single cell technologies.